Long distance regressive signaling underlies sculpting of the nervous system during development.

PROJECT SUMMARY
Neurodevelopmental events occurring after axons innervate their targets can be categorized as either
progressive (e.g., cell survival, axon stabilization, promotion of synapse formation) or regressive (e.g., cell death,
axon degeneration, synapse restriction). While the molecular and cellular basis of long-distance progressive
signaling is relatively well-characterized, the understanding of long-distance regressive signaling remains limited.
Many target-derived regressive cues, such as trophic factor deprivation (TFD), repulsive axon guidance cues,
neurotrophin and pro-neurotrophin binding, converge on the p75 neurotrophin receptor (p75NTR). Studying this
single receptor offers an opportunity to explore the molecular basis of various long-distance regressive signaling
events. This research holds significance for understanding neurodevelopmental disorders such as autism and
schizophrenia, as well as a wide range of neurodegenerative conditions, including ALS, Huntington's,
Parkinson's, and Alzheimer's disease.
The mechanism regulating the transmission of target-derived regressive cues back to the cell body is an
emerging area of study. Currently, there is a significant gap in our knowledge regarding how p75NTR
transitions from the plasma membrane to endosomal signaling and from the axon to the cell soma. The general
concept motivating this application is that p75NTR must be internalized, cleaved, and palmitoylated to traffic
and convey long-distance degenerative signals. However, it is unclear whether all regressive ligands and trophic
factor deprivation relying on p75NTR require each of these events or how progressive signals interfere with these
processes. The rationale for this proposal is based on our preliminary findings that: 1) p75NTR is cleaved and
becomes endosomally associated after distal axon treatment with a regressive cue, and 2) palmitoylation of
p75NTR is required for endosomal localization and retrograde death signaling. The exact regulatory mechanism
behind this remains an open question. In Aim 1, we will characterize the features of p75NTR long-distance
regressive signaling during apoptosis, axon degeneration and synapse restriction, as well as investigate how
crosstalk from NGF-TrkA progressive signaling influences these processes. In Aim 2, we will examine the role
of p75NTR palmitoylation in regressive signaling and assess the physiological effects of palmitoylation on
regressive developmental events in vivo. Our overarching goal is to unravel the role of long-distance regressive
signaling in nervous system development and its regulation.

Public health relevance
PROJECT NARRATIVE Elucidating the cellular and molecular mechanisms that underlie long-distance regressive signaling, which regulates neuronal death and axon degeneration, presents a novel perspective on nervous system patterning. The proposed research carries substantial significance, as the insights gained will enhance our understanding of the etiology and progression of pathologies that negatively impact the nervous system's structure, such as Amyotrophic Lateral Sclerosis (ALS) and Alzheimer's disease.